In situ capsid protein and DNA imaging platform for the characterization of therapeutic adeno-associated virus (AAV) titers

Project Summary
Adeno-associated virus (AAV) is the leading gene delivery vector for treating different human diseases. Some
AAV therapies have been approved for use in the clinic and constitute an essential step toward personalized
gene therapy. However, despite its promise to treat many genetic diseases, AAV gene therapy still face many
safety challenges that lead to several adverse events, including death. In most cases, these adverse events
were related to the use of AAVs with high vector genome (vg) titers (>1E14 vg/kg). Despite following a multi-step
purification process, these AAV preparations are often contaminated with non-therapeutic AAV particles, such
as empty or partial AAV capsids (lacking or containing truncated vg) and cross-packaged DNA. These
contaminants can contribute to adverse events at high AAV vg titers even when present in lower ratios.
Accordingly, the success of AAV therapies relies on the use of high-quality AAV capsids (qualified to package a
high majority of full therapeutic AAV vg and minimal levels of contaminants) and on the precise quantification of
AAV titers to ensure optimal dosage, efficacy and safety. The current analytical methods used to ensure the
production of high-quality AAV are not comprehensive and thus lack the precision needed for the accurate and
reproducible quantification of AAV vg, capsid and contaminant titers. These limitations result in a misestimation
of the empty/partial/full AAV capsid ratio, leading to the administration of either low AAV vg titers with sub-optimal
therapeutic efficacy or high AAV vg titers with toxic levels of contaminants, potentially causing severe adverse
events or death in treated patients. Therefore, there is an unmet need for developing analytical methods that
provide an efficient, cost-effective, and easy implementation for the comprehensive, accurate, and reliable
quantification of AAV capsid and genomic titers and AAV integrity.
In this proposal, we are set to develop a unique and groundbreaking QC platform that we named “AAVBiochip.”
It will be an essential in situ single particle analytical tool to determine capsid and vg titers and the ratio of
empty/partial/full AAV capsids in a single assay. We will immobilize AAVs on the platform surface by electrostatic
interactions for rapid imaging and analysis. In Aim 1, we will demonstrate the feasibility of our technology by
using well-characterized AAV titers for which the capsid proteins, conformational epitope (3D structure) of
assembled capsids, and ITR genomic regions will be targeted using specific antibodies and sensitive molecular
beacons. We will also compare our measurements with standard methods for quantifying AAV titers, ensuring
the accuracy and reliability of our results. In Aim 2, We will conduct a comprehensive benchmarking comparison
using different AAV serotypes approved by the FDA for gene therapies. AAVs will be engineered to carry the
green fluorescence protein (GFP) payload. For the analytical characterization of these AAV capsids, a
combination of standard analytical methods and the AAVBiochip will be used. Overall, our work will enable a
comprehensive, ultrasensitive and accurate AAV characterization technology that will offer significant
advantages as a QC tool for any AAV-based gene therapy.

Public health relevance
Narrative To date, different analytical techniques are required for the comprehensive characterization of Adeno- Associated Virus (AAV) that is used as a powerful delivery vector for gene therapy products. We will address this challenge with the development and validation of a technology (AAVBiochip) that will enable comprehensive, accurate, and reliable capsid and genomic titers quantifications, and provide a precise quantification of DNA cross-packaging and the ratio of empty/partial/full AAV capsids in one single assay. AAVBiochip will allow the production of high-quality and safe AAV vectors for gene therapy applications.